Regulation of Enteric Nervous System Function by Group 3 Innate Lymphoid Cells

PROJECT SUMMARY
The enteric nervous system (ENS) is critical for controlling key intestinal functions such as peristalsis and nutrient
absorption. Emerging paradigms indicate that interactions between neurons and immune cells fundamentally
impact immunity and inflammation in peripheral tissues. Recently, it has been shown that the ENS can act on
the intestinal immune system to modify the function of innate lymphoid cells (ILCs). However, despite these
advances, the role of ILCs in ENS function remains unexplored. In my preliminary studies, I defined that ILCs
are genetically poised to interact with the ENS and support their development or function. By examining a specific
factor produce by ILCs, I defined how it is regulated and developed a lineage-specific knockout to demonstrate
this pathway plays a role in augmenting the ENS. To goals of this proposal are, in Aim 1, to utilize in vivo and ex
vivo models to determine the molecular mechanisms that regulate ILCs and associated factors, and, in Aim 2,
to determine the cellular mechanisms by which ILC-derived factors impacts the ENS and the importance of this
interaction in maintaining ENS homeostasis during inflammation. Collectively, these two aims will critically define
a novel molecular mechanism by which ILCs impact ENS function in states of intestinal health and disease,
which could provoke novel preventative, therapeutic or curative strategies. Further, it will create an outstanding
training opportunity for my continued development in science and eventual transition to become an independent
academic researcher.

Public health relevance
PROJECT NARRATIVE The enteric nervous system is the largest collection of peripheral neurons that function independently of the central nervous system and are critical for controlling key intestinal functions, including motility, nutrient handling, and immune regulation, which have been shown to be dysregulated in the context of inflammatory bowel disease (IBD), irritable bowel disorder (IBS), colon cancer, or during enteric infection. Therefore, a deeper understanding of the mechanisms by which the intestinal immune cells impact the function of enteric neurons is essential for elucidating the link between these two systems. This proposal will investigate the mechanism by which intestinal innate lymphoid promote ENS homeostasis during states of health and disease.